Multiplexed transcription factor profiling of complex mixtures and developmental toxicants for the NTP

The integrated and coordinated NR signaling networks modulate transcription of many target genes that are essential for normal human development. The Attagene platform provides a unique (patented) multiplexed reporter technology that enables the assessment of individual chemicals and complex mixtures with respect to activating human transcription factors. Keywords: toxicity, toxicognenomics, herbal, developmental.